Structural mechanisms of sliding clamp loader ATPases

Project Summary/Abstract
All life forms require a ring-shaped sliding clamp to coordinate replication of their genome. These sliding
clamps act as master regulators of DNA replication, coordinating replisome action with other cellular
processes. These master regulators are themselves regulated by large ATPase machines called clamp loaders
that either install or remove sliding clamps from DNA. This project seeks to gain an atomic-level understanding
of clamp loader mechanism. These protein remodeling machines open the sliding clamp ring as a key step in
their action. We have found that in the key intermediate complex—consisting of an open clamp, an ATP-bound
clamp loader and the target DNA—the protein components form an open spiral that matches the helical
symmetry of DNA. This symmetric spiral activates ATP hydrolysis leading to clamp closure and release of the
loaded clamp. In Aim 1, we now turn our attention to the critical first two steps of the reaction: the opening of
the clamp and the binding of DNA to the inner chamber of the complex. We will identify the conformational
changes in the clamp loader complex that allow for opening the clamp ring, as well as how the assembly can
rapidly bind a specific DNA structure in the tight confines of the complex's interior. In Aim 2, we investigate how
the single subunit change in the clamp loader complex (Rfc1 replaced with Elg1) converts a dedicated clamp
loader into a dedicated unloader. This work will not only reveal the mechanism and structure of a key protein
involved in cancer development, but will also provide a blueprint for how an ATPase machine can be
reprogrammed to perform a reverse reaction.
Finally, in Aim 3 we explore how replacement of the Rfc1 subunit with the Ctf18 protein leads to an assembly
that is bifunctional as both a loader and unloader, and that connects DNA replication to the process of sister
chromatid cohesion. Our structures and analysis of this complex will reveal how an ATPase machine can be
mechanistically flexible to catalyze both forward and reverse reactions. In addition, this work will provide insight
into how this mysterious complex can link the seemingly disparate processes of DNA replication and sister
chromatid cohesion. Because clamp loaders and sliding clamps are fundamental to all life, the structural
insights that we obtain from completing our aims will be used for developing novel antimicrobial or
chemotherapeutic drugs.

Public health relevance
Project Narrative Sliding clamps are proteins that are critical to the copying of DNA. These ring-shaped proteins are installed or removed from DNA by clamp loaders. Sliding clamps and clamp loaders are important for cellular proliferation and cancer development. We will uncover how sliding clamps are put onto or removed from DNA. We will determine these processes in atomic detail. This work will provide an understanding of how nature’s nanomachines have evolved to do mechanical work, and will also provide a blueprint for how to target sliding clamp loaders for chemotherapy or antimicrobial therapy.